Optical gearbox for high speed neural recording

The rapid advance of genetically encoded functional indicators allows the scientists to visualize
neuronal activities with light in the living brain at high spatiotemporal resolutions. For in vivo
measurement in the mammalian brain, laser scanning two-photon fluorescence microscopy
(TPM) is commonly employed to image the neurons expressing genetically encoded functional
indicators. The sequential point scanning of TPM offers clean measurement without noise
crosstalk and yields excellent signal-to-noise ratio. However, the commonly employed systems
are designed to accommodate single-plane recording at ~10 Hz rate. The emerging high-speed
glutamate sensors and voltage indicators often require much greater frame rate (e.g. 400-1000
Hz). Moreover, for 3D multiregional recording of calcium indicators (e.g. 20 sub image planes at
40 Hz), image frame rate near 1000 Hz is also required.
Here we propose to develop an optical gearbox, which as an add-on unit can convert
commonly used laser scanning two-photon microscopes for high frame rate recording. The
essence of optical gearbox is to conserve the maximum overall data throughput of an imaging
system and allow the users to gain scanning line rates at the cost of imaging field-of-view (FOV).
For laser scanning microscopes based on galvo, resonant galvo or polygon scanners, the
system achieves the highest data throughput only at full FOV scanning. Zoom (reducing FOV)
leads to proportionally reduced data throughput. In comparison, with optical gearbox, there will
be no loss on data throughput. Based on the optical gearbox, we will develop the capability for
two applications. One is the high frame rate 2D imaging suitable for glutamate and voltage
sensors and the other is to distribute the kHz frame rate for multiple regions in 3D for
multiregional calcium imaging (e.g. image tens of 3D regions at tens of Hz rate). The
development of this add-on converter will enable high speed 3D imaging with the existing two-
photon microscopes without the need to have specialized and expensive new laser sources,
hardware and software. This development will broadly facilitate the research community to take
advantages of the advance of high-speed functional indicators in neuroscience research.

Public health relevance
The proposal is to develop a novel high-speed neural recording system for neuroscience research. The imaging system will greatly facilitate understanding changes of brain activity under normal and pathological conditions.